CVL-354, a kappa opioid receptor antagonist for treatment of opioid use disorder, withdrawal and relapse

PROJECT SUMMARY
Kappa opioid receptors (KOR) are expressed in brain areas that control reward, motivation, and anxiety.
Dynorphin (DYN), an endogenous KOR agonist controls KOR activity to promote physiological acute aversive
states such as fear and anxiety to promote escape. Furthermore, upon opioid drug withdrawal and abstinence,
dysregulated DYN/KOR signaling can result in aversive physical and affective states that are a major driver of
relapse. Preclinically, KOR antagonists have demonstrated efficacy in reducing the physical signs of acute opioid
withdrawal. The current standard of care administered to reduce the physical symptoms of opioid withdrawal is
the alpha 2a adrenergic receptor agonist, lofexidine. Although approved, lofexidine is only modestly effective at
withdrawal symptom severity reduction and can have significant unwanted side effects such as hypotension,
acute orthostasis and syncope, QT prolongation, and the potentiation of CNS depressant effects when taken
with sedating drugs. Cerevel Therapeutics is addressing this unmet need with the development of a short-acting,
selective KOR antagonist. This compound, CVL-354, attenuated the physical signs of withdrawal in an acute
opioid withdrawal model in rodents and we have completed a comprehensive nonclinical safety package that will
support dosing up to 90 days in humans. If awarded these funds, we are poised to run single and multiple
ascending dose studies to assess safety and tolerability in healthy volunteers (UG3 portion). In the UH3 portion
we will execute PET studies to further explore receptor occupancy in human, in combination with additional
nonclinical safety and manufacturing work that will support a Phase 2 clinical trial aimed at providing a more
effective treatment option to mitigate the physical symptoms of opioid withdrawal.

Public health relevance
PROJECT NARRATIVE Preclinical data have demonstrated that antagonism of kappa opioid receptors (KOR) is efficacious in reducing the physical symptoms of opioid withdrawal. Currently, the alpha 2-adrenergic agonist lofexidine is the only approved therapy for the mitigation of the physical symptoms of opioid withdrawal but it is only modestly effective and can have significant unwanted side effects. In this application, Cerevel Therapeutics has identified a novel selective KOR antagonist with unique properties and good preclinical safety margins that we are planning to take through early human safety/pharmacokinetics and occupancy studies, into a Phase 2 study to assess efficacy in acute opioid withdrawal.